Restoring Tolerance in Inflammatory Bowel Disease with an Oral AMPK agonist Nanomedicine that Targets Antigen Presenting Cells.

PROJECT SUMMARY
In the United States alone, approximately 3.1 million adult patients suffer from inflammatory bowel disease (IBD),
a group of disorders characterized by chronic or recurring inflammation of the gastrointestinal (GI) tract. Although
several therapeutics, including anti-TNF antibodies, have been approved for the treatment of IBD, many patients
do not respond to current treatments or experience relapse, highlighting an urgent need for the development of
more effective long-term therapies.
Antigen presenting cell (APC) dysfunction drives IBD initiation by encouraging a breakdown in intestinal
homeostasis and promoting pathogenic proinflammatory circuits against harmless commensal microbes.
Although APCs are considered critical to IBD pathogenesis, there have been no APC-targeted therapies
developed to date for the treatment of IBD. Qrono Inc is developing QR401, a first-in-class, oral, APC-specific
AMPK pathway agonist for the treatment of IBD. QR401 uses custom nanoparticles to directly promote an AMPK-
induced immunoregulatory APC phenotype. This work is inspired by studies demonstrating 1) that the AMPK
pathway is downregulated by intestinal APCs in IBD patients and 2) that activation of the AMPK pathway via oral
or systemic administration of AMPK pathway agonists can successfully alleviate disease severity in preclinical
mouse studies. While AMPK has long been a target of interest for IBD, clinical development of AMPK agonists
has been limited by severe adverse effects associated with systemic administration including metabolic
complications (i.e. lactic acidosis) and cardiac hypertrophy. Thus, approaches like the one we propose that can
target AMPK agonists specifically to intestinal APCs are vital to safely activating the AMPK pathway that’s
dampened in IBD and restoring tolerance. Our preliminary data identify the AMPK agonist PF-739 as having
tolerogenic activity, marked by a dampening of pro-inflammatory IL-12p70 production coupled with a significant
increase in anti-inflammatory IL-10 secretion in LPS stimulated dendritic cells (DCs), features that promote Treg
induction. We hypothesize that targeting AMPK-activating compounds to APCs will decrease intestinal
inflammation during experimental colitis and human IBD without the metabolic and cardiac risks
historically associated with untargeted AMPK agonists. Accordingly, we will prepare and characterize
enteric-coated nanoparticles of PF-739 (QR401) that can be used for the proposed in vivo studies.
Successful completion of this project will establish proof-of-concept for a first-in-class APC-targeted
immunotherapy for IBD. A future Phase II STTR proposal would continue development in IND-enabling studies.
Qrono is committed to developing oral tolerogenic therapies for IBD, and these data will help us raise private
investment necessary for future clinical trials.

Public health relevance
PROJECT NARRATIVE A breakdown in antigen presenting cell (APC) tolerance towards intestinal microbiota plays a critical role in the initiation and perpetuation of inflammation in inflammatory bowel disease (IBD). This proposal seeks to test whether QR401, an APC-targeted AMPK agonist designed to restore tolerogenic APCs in the GI tract, can alleviate intestinal inflammation and disease severity in proof-of-concept murine models of IBD. Successful completion of the proposed project will result in the validation and development of a first-in-class, oral, APC- specific nanotherapy, which could provide a much-needed treatment option for IBD patients.